Assembly and Dynamics of Molecular Machines in Genome Maintenance

ABSTRACT
Efficient DNA repair is a double-edged sword. Accurate repair of such deleterious DNA lesions as double-
stranded breaks, inter-strand crosslinks, and damaged replication forks promotes genome stability. It also
allows cancer cells to acquire a more aggressive character and develop resistance to radiation and DNA
damaging chemotherapeutics. Additionally, untimely deployment and/or misregulation of the DNA repair
machines may further destabilize the genome (which can lead to cancer) or may result in the accumulation
of toxic repair intermediates (which can lead to cell death). Significant gaps remain in our understanding of
the molecular events that funnel the intermediates of otherwise accurate repair into “rogue”, genome-
destabilizing mechanisms.
This research program emphasizes the molecular machinery of homologous recombination, how it is
integrated into DNA replication, repair and recombination (the 3Rs of genome stability), and how it is
misappropriated in the molecular pathways that process stalled DNA replication events and DNA breaks
through highly mutagenic, genome destabilizing mechanisms.
Our central hypothesis is that the activities of the RAD51 recombinase, the ssDNA-binding protein RPA,
recombination mediators BRCA2 (in human) and Rad52 (in yeast), and DNA repair helicases are finely tuned
by a variety of factors, which include posttranslational modifications, interacting partner proteins, specific DNA
structures and DNA lesions. These factors affect the protein conformational dynamics and critical protein-
protein interfaces. Understanding how the protein plasticity and kinetics of assembly of the macromolecular
machines of DNA repair will show us new ways to selectively manipulate the activities of RAD51 and
multifunctional DNA helicases in DNA replication and repair.
We are leveraging and building the tools of single-molecule biochemistry, biophysics and chemical biology.
Our unique perspective on the formation, activities and regulation of the nucleoprotein complexes
orchestrating recombination is rooted in our ability to sort individual human DNA repair proteins with their
native posttranslational modifications, and to probe and separate activities associated with different surface-
tethered proteins and nucleoprotein complexes at the single-molecule level. Our goal is to provide an entirely
new outlook on how the cell balances the assembly and activities of the molecular machines that can repair,
but also destabilize, the genome, and to be able to alter this balance with new anticancer chemotherapeutics.

Public health relevance
Molecular machinery of homologous recombination maintains integrity of the genome by promoting faithful repair of the most genotoxic DNA lesions and faithful genome replication. Defects in its regulation can lead to genetic instability and chromosomal rearrangements causing cancer, aging, and diseases associated with progressive expansion of repeated sequences (including myotonic dystrophy and Fragile X syndrome). Understanding the fundamental molecular mechanisms of how recombination is regulated and its dysregulation will reveal features, which can be exploited in developing novel anticancer therapeutics.